SYMPOSIUM ON ORAL MUCOSAL DISEASES

It is proposed to organize a three-day Symposium on the Biology, Etiology, and Therapy of Oral Mucosal Diseases. The aim of the symposium will be to discuss and disseminate the results of recent mucosal and pharmacological research and to examine their relevance to the development of interceptive and therapeutic regimes. The symposium will be structured around a series of formal presentations but with approximately half of the meeting time devoted to discussion. Transcripts of the discussion will be edited and together with reports of the individual presentations will be published.